Caveolin-Mediated Neuroplasticity in Alzheimer's Disease and in Human Neurons Harboring EOFAD Mutations

Age is one of the highest risk factors for Alzheimer’s disease (AD) with approximately 5.5 million people age 65
and older living with AD in the U.S., a number estimated to grow to 13 million by 2050. AD is closely
associated with decreased neuronal signaling and loss of synapses [and mitochondrial dysfunction]. The
increasing number of individuals and rising healthcare costs associated with AD are further compounded by a
growing population of younger Veterans, who have increased risk of AD and other forms of dementia. Although
the accepted etiology of AD pathology is the buildup of toxic amyloid-­b (Ab) plaques, interventional strategies
intended to remove Ab plaques have demonstrated significant side effects resulting in failed clinical trials.
Therefore, there is great demand for neuroprotective strategies to preserve [mitochondrial function], restore
neuronal and cognitive function, independent of solely targeting Ab. [In the setting of AD, mitochondrial
dysfunction significantly contributes to the neuropathology. Mitochondria dynamics (i.e., fusion and fission),
which serve to maintain normal mitochondria structure and function during stress, are altered in AD.
Therefore, targeting molecular complexes that transduce signaling from the plasma membrane to the
mitochondria may afford neuroprotection and resilience within an otherwise neurotoxic environment.] One
potential neuroprotective target is caveolin-­1 (Cav-­1), a membrane/lipid raft (MLR) and scaffolding protein. Pre-­
clinical and clinical evidence shows that Cav-­1 and Cav-­1 associated [synaptic] signaling complexes are
decreased in degenerating neurons [during] AD, chronic traumatic encephalopathy (CTE), and amyotrophic
lateral sclerosis (ALS). Recent work shows that Cav-­1-­mediated axodendritic growth is in part dependent upon
Cav-­1 phosphorylation at tyrosine 14 (Y14). [Preliminary data show that hippocampal Cav-­1 is decreased in 6
month (m) old PSAPP mice, a time point at which these mice also exhibit impaired learning. Further evidence
shows that hippocampal Cav-­1 subcellular localization to mitochondria is significantly decreased in 12 m old
PSAPP mice that exhibit severe memory deficits. Neuron-­targeted Cav-­1 re-­expression using AAV-­SynCav1
prevents hippocampal memory deficits and neurodegeneration in PSAPP] mice [through augmenting] synaptic
strength and [resilience] to neurotoxic Aβ and astrogliosis. [Furthermore, SynCav1 delivery to PSAPP mice
restores Cav-­1 localization to mitochondria, mitigates mitochondria morphological damage, enhances
mitochondria metabolism, and maintains mitochondria fission and fusion balance. A major limitation to our
current findings is the use of a single AAV-­SynCav1 dose (10 x 109 g.c./ul) in pre-­symptomatic PSAPP mice (3
m) that produces Cav-­1 protein expression considerably higher than wild type brains;; a dose that may lead to a
‘ceiling effect’ in terms of efficacy. Therefore, the objective of this revised Merit(A1) application is to determine
the optimal AAV-­SynCav1 dosing regimen in symptomatic PSAPP mice (6 m) that restores or improves 1)
plasticity and cognitive function and 2) mitochondrial dynamics at 9, 12, and 15 m of age, and 3) to determine
whether Cav-­1-­mediated neuroplasticity and mitochondrial energetics is dependent upon P-­Cav-­1(Y14) using
human iPSC-­derived neuron cell lines from patients harboring three distinct EOFAD-­linked mutations
(APPV717L, PSEN1A246E, and PSEN2N141l). Aim 1 will determine which optimal AAV-­SynCav1 dose (0.5, 1.0,
2.0 x 109 g.c./ul) administered to 6 m old PSAPP mice enhances neuronal and synaptic plasticity and
restores cognitive function at 9, 12, and 15 m;; Aim 2 will determine which optimal AAV-­SynCav1 dose
(0.5, 1.0, 2.0 x 109 g.c./ul) administered to 6 m old PSAPP restores mitochondrial biochemistry,
dynamics, and function at 9, 12, and 15 m;; and Aim 3 will determine whether P-­Cav-­1(Y14) is necessary
for neuroplasticity (i.e., axonal transport, dendro-­axonal growth) and mitochondrial energetics in
human neurons harboring EOFAD mutations (APPV717L, PSEN1A246E, and PSEN2N141l).]

Public health relevance
Gene therapy is a promising approach for treating neurodegenerative diseases such as Alzheimer’s disease (AD). AD is closely associated with decreased neuronal signaling and loss of synapses. Interventional strategies intended to remove Ab plaques have failed clinical trials. Therefore, there is great demand for neuroprotective strategies to preserve neuronal and cognitive function, independent of targeting Ab., to treat male and female veterans with AD. One potential alternative target is caveolin- 1 (Cav- 1), a membrane/lipid raft (MLR) and scaffolding protein within the neuronal plasma membrane. When delivered in vivo, neuron- targeted Cav- 1 over- expression (using a synapsin promoter) increases hippocampal MLR- localized TrkB, neuronal and synaptic plasticity, and improves memory in aged mice. This Merit application will be a major advancement to further demonstrate and better understand Cav- 1- mediate neuroprotection and neuroplasticity in AD mice and human neurons derived from iPSCs from early onset familial AD (EOFAD) patients.